Core C

Core C: ABSTRACT
Core C will support Projects 1-3 in their data analysis, ensuring that these analyses are conducted by rigorous
methods and making the data interpretable and reproducible. Core C will pay attention to data types and
statistical power, while taking into account important confounding factors that are present in the human
population. Core C will, in addition, implement a new method called Shifting Pair Analysis (SPA), based on k-
Top Scoring Pairs (kTSP) that was originally invented by Dr. Geman (a PI of this Core) in 2004. Core C MPIs
have made fundamental contributions to computational biology (e.g., the introduction of Gibbs sampler and
random forests). Taking advantage of their expertise, Core C will provide standardized analytic pipelines for
general data analysis, such as power analysis and sample size estimation, group comparison, correlation
analysis, and other statistical analyses (Aim 1). Furthermore, Core C will provide customized analytic pipelines
and guidance for molecular data analysis (Aim 2), and neuroimaging and multimodal data analysis (Aim 3).
Core C will also provide guidelines for controlling confounding factors and biological variables in molecular,
neuroimaging, and multimodal data analyses. Core C will assist Projects 1 and 3 in investigating pathological
changes in the olfactory epithelium (OE), particularly immune/inflammatory changes and redox imbalance,
across humans and mice through immunohistochemistry, single-cell RNA-sequencing, and bulk RNA-
sequencing. To study the impact of the OE pathology on clinical manifestations in schizophrenia (SZ) via the
olfactory-prefrontal circuits, Core C will guide Project 3 to identify key molecules for the OE pathology in SZ,
sub-stratify SZ patients, and perform causal mediation analysis to study relationships among OE pathology,
olfactory-prefrontal circuits, and clinical manifestation. Core C will also guide Project 1 to analyze mouse ex
vivo brain imaging data, assist Project 2 in analyzing mouse electrophysiological data and comparing the
connectivity of the olfactory-prefrontal circuits between control mice and human healthy subjects. In addition,
Core C will guide Project 3 to conduct a pilot longitudinal study. In summary, Core C will support Projects by
central guidance in data analysis using conventional methods in psychiatry and other medical research (Aims
1-3). The other important and innovative role of Core C is to implement a new method (SPA) (Aim 4). This is a
modified version of kTSP, which has been used in cancer and other disease research, in particular enormously
contributing to biomarker exploration. But this method has not yet been applied to psychiatry. SPA is
advantageous in prioritizing key molecules in samples with high heterogeneity via analyzing relationships
between variables, which is less affected by confounding factors. SPA will be used in Projects as an
explorative approach to validate the results in a more sensitive manner. Together, Core C will provide
integrative data science support with both solid/conventional and innovative/novel analytical pipelines.